Defining the genetic architecture of multiple stress response

ABSTRACT
The goal of this work is to understand the fundamental biology of cellular response to different forms and
combinations of stress. Cells are constantly subjected to intrinsic and extrinsic stresses—reactive oxygen
species, protein misfolding, osmotic stress—that negatively impact cellular structure and function. In response,
cells activate a range of molecular pathways to mitigate and repair damage—oxidative stress response, unfolded
protein response, osmotic stress response. Several interventions that improve health, such as dietary restriction,
both activate stress response pathways and promote multi-stress resistance. While individual stress response
pathways are reasonably well defined, how stress responses differ when cells are challenged with multiple forms
of stress simultaneously is less well understood and represents a critical knowledge gap. This gap has broad
implications for medicine. Human diseases rarely involve a single form of stress—Alzheimer’s disease is
characterized by neuroinflammation, increased oxidative stress, and accumulation of misfolded proteins, while
cancer exhibits oxidative stress, DNA damage, and localized hypoxia. By understanding the network of molecular
pathways that define cellular stress response, we aim to identify intervention points that can be targeted to
activate distinct stress response profiles that improve health, combat disease, and enhance resilience. The long-
term goal of this research program is to answer fundamental questions about the biology of stress response:
(1) How is the molecular stress response network organized? (2) Which elements of this network are general
(responsive to many types of stress) and which are specific (responsive to specific stressors)? (3) How does the
cellular response to one type of stress alter an organism’s resistance to other types? (4) Are there key molecular
nodes in the stress response network that can be targeted to improve health or treat specific diseases? Over the
past five years we have examined the physiological and molecular response of the round worm Caenorhabditis
elegans to a range of stress combinations. In parallel, we studied C. elegans and mice with elevated levels of the
tryptophan metabolite 3-hydroxyanthanilic acid (3HAA) as models of multi-stress resistance. Evidence from these
projects converged on heavy metal regulation and host-bacteria intercommunication as molecular processes
responsive to many types and combinations of stress. We are now focused on answering several questions
related to these molecular themes: (1) What role does heavy metal transport and storage play in the response to
diverse stressors? (2) How does the response of intestinal bacteria to stress impact host health and stress
resistance? (3) Can these processes be targeted to promote animal health and resilience? (4) How do changes
in intestinal iron and zinc localization promote broad-spectrum stress resistance in animals with elevated 3HAA?
Beyond these questions, we will continue our search for novel stress interactions in pursuit of our broader goal to
comprehensively understand the cellular stress response network. Supporting each of these projects, we
continue to build innovative, high-content tools for studying stress response in C. elegans.

Public health relevance
NARRATIVE Because humans and other organisms constantly encounter different combinations of stress in our day-to-day environments and human diseases are characterized by distinct combinations of elevated cellular stress, understanding the molecular processes that cell’s use to respond to stress is an important problem for human health. We understand reasonably well how cells and organisms respond to individual stressors, but less is known about how these responses change when cells are challenged with multiple simultaneous forms of stress. The goal of this research is to understand how cells and organisms respond when challenged with multiple, distinct forms of stress.